NIDA Clinical Trials Network: Big South/West Node Supplemental - CURB CTN0109 & KMD CTN0132

Yr20 Supplement Request
Abstract
CTN-0109 Randomized, placebo-controlled trial of extended-release naltrexone and monthly extended-
release buprenorphine for cocaine use disorder (CURB-2)
This is an 8-week, double-blind, randomized placebo-controlled trial to determine the efficacy of a combination
of extended-release naltrexone (XR-NTX) and extended-release buprenorphine (XR-BUP) compared to
placebo injections (PBO-Inje) for the treatment of cocaine use disorder (CUD). The primary objective is to
evaluate whether assignment of 8 weeks of outpatient XR-NTX + XR-BUP compared to PBO-Inje reduces
urine-verified cocaine use in study Weeks 5 through 8. The primary outcome measure is the proportion of
cocaine-negative urine drug screens (UDS) obtained during Weeks 5 through 8 as measured for the XR-NTX +
XR-BUP and PBO-Inj conditions. The secondary objective is to evaluate the effect of assignment to 8 weeks of
XR-NTX + XR-BUP compared to PBO-Inj on self-report days of cocaine use, cocaine craving, safety, and
treatment effectiveness. The secondary outcome measures are 1) Self-reported days of cocaine use and
cocaine craving effects (Visual Analog Scale (VAS)) during Weeks 0-8; 2) Measures of adverse events during
Weeks 0-8: number and severity of adverse events; number and outcomes (fatal/non-fatal) of overdose events
reported; 3) Measures of Treatment Effectiveness Assessment (TEA) at Week 8.
Yr20 Supplement Request
Abstract
CTN-0132 Randomized, Double-Blind, Active Placebo-Controlled Trial of Ketamine for
Methamphetamine Use Disorder (KMD)
This is a 12-week randomized, double-blind, controlled trial comparing intravenous (IV) ketamine against IV
midazolam delivered over six weeks (acute phase of twice-weekly infusions during Weeks 1, 2, and 3, and one
infusion during Week 4, followed by continuation-phase of one infusion during Week 6; total of eight (8)
infusions over the six-week period) in 120 adults (30 per site) with moderate to severe methamphetamine use
disorder (MUD) (without co-existing opioid use disorder [OUD] of moderate to severe severity).

Public health relevance
Yr20 Supplement Request Narrative CTN-0109 Randomized, placebo-controlled trial of extended-release naltrexone and monthly extended- release buprenorphine for cocaine use disorder (CURB-2) Currently there are no pharmaceutical treatments for cocaine use disorder (CUD). This study is an 8-week, double-blind, randomized placebo-controlled trial to determine the efficacy of a combination of extended- release naltrexone and extended-release buprenorphine compared to placebo injections for the treatment of CUD. Yr20 Supplement Request Narrative CTN-0132 Randomized, Double-Blind, Active Placebo-Controlled Trial of Ketamine for Methamphetamine Use Disorder (KMD) Currently there are no pharmaceutical treatments for methamphetamine use disorder (MUD). This study is a 12-week randomized, double-blind, controlled trial comparing intravenous (IV) ketamine against IV midazolam, delivered over six weeks in adults with moderate to severe methamphetamine use disorder (MUD).